GENE TRANSFER VEHICLE

The gene transfer vehicle core will synthesize, purify and supply sterile reagents for nucleic acid transfection to researchers involved with gene therapy at the University of California, San Francisco.